Novel chaperones and neurodegeneration

Abstract
The polyglutamine (polyQ) diseases are a class of nine neurodegenerative diseases caused by the expansion
of a polyQ tract in specific proteins. Expansion of the polyQ tract results in protein aggregation and
neurodegeneration. Currently there are no curative treatments for the polyQ diseases. One potential therapy for
the polyQ diseases is the development of strategies to reduce polyQ aggregation. Interestingly we and others
have found that one organism, Dictyostelium discoideum, is naturally resist to polyQ aggregation. Further work
from our laboratory has identified a novel molecular chaperone we named serine rich chaperone protein 1
(SRCP1) that is both necessary for Dictyostelium’s resistance to polyQ aggregation and sufficient to impart
resistance to polyQ aggregation to other organisms. In this application we propose to 1) determine the molecular
mechanism SRCP1 utilizes to recognize polyQ expanded proteins and suppress their aggregation; 2) determine
if SRCP1 can suppress protein aggregation and behavioral deficits in a mouse model of Huntington’s disease;
and 3) determine if SRCP1 is capable of suppressing polyQ aggregation in a mouse model of Spinocerebellar
ataxia type 3. Together these studies will determine the mechanism SRCP1 utilizes to suppress polyQ
aggregation and determine if SRCP1 has the ability to prevent or reverse disease phenotypes in mouse models
of polyQ disease.
!

Public health relevance
Project Narrative The work proposed here will determine how serine rich chaperone protein 1 (SRCP1) functions to suppress polyglutamine aggregation. The proposal will also determine if SRCP1 is effective at preventing or reversing disease phenotypes in mouse models of Huntington’s disease and Spinocerebellar ataxia type 3. Completion of this work may provide new insight into the development of novel therapeutics to treat the polyglutamine diseases.